Maryland Manufactured Food Flexible Funding Model Compliance and Enforcement Expansion Supplement

Funding Opportunity Title: Manufactured Food Flexible Funding Model
Compliance and Enforcement Expansion Supplement (U18)
Funding Opportunity: RFA-FD-22-019
Agency: Maryland Department of Health
Abstract
The purpose of this funding is to advance the efforts of the Maryland Department of
Health (MDH) and a nationally Integrated Food Safety System (IFSS) by assisting the
MDH Office of Food Protection’s (OFP) manufactured food regulatory program and the
State of Maryland Rapid Response Team (SMarRRT) through the enhancement of their
existing regulatory and compliance activities. The objectives of the grant will be to
increase efficiency and effectiveness associated with responses to violative food
samples identified within the State of Maryland. In addition, it will allow OFP to provide
additional support to the Maryland State Public Health Laboratory (MSPHL) through its
participation in the Laboratory Flexible Funding Model (LFFM) Program.

Public health relevance
Funding Opportunity Title: Manufactured Food Flexible Funding Model Compliance and Enforcement Expansion Supplement (U18) Funding Opportunity: RFA-FD-22-019 Agency: Maryland Department of Health Abstract The purpose of this funding is to advance the efforts of the Maryland Department of Health (MDH) and a nationally Integrated Food Safety System (IFSS) by assisting the MDH Office of Food Protection’s (OFP) manufactured food regulatory program and the State of Maryland Rapid Response Team (SMarRRT) through the enhancement of their existing regulatory and compliance activities. The objectives of the grant will be to increase efficiency and effectiveness associated with responses to violative food samples identified within the State of Maryland. In addition, it will allow OFP to provide additional support to the Maryland State Public Health Laboratory (MSPHL) through its participation in the Laboratory Flexible Funding Model (LFFM) Program.